Pilot and Feasibility Program

Abstract - Pilot and Feasibility Program
The objective of the Pilot and Feasibility (P&F) program is to serve the University of Washington's Cystic
Fibrosis Research Translation Center's (CFRTC) mission of advancing cystic fibrosis (CF) research to improve
the health of people with CF. The P&F program will contribute to this mission by recruiting young scientists,
established investigators who have not previously worked in CF, and accomplished CF researchers who are
pursuing novel and high-risk ideas that represent a clear departure from their established work.
Aim 1. To recruit outstanding early stage and established investigators to CF research in NIDDK
interest areas. We will engage promising investigators via personal outreach; interactions with academic and
research leaders; and our CF-focused seminars, research meetings, and annual retreat.
Aim 2. To manage the P&F program to maximize the scientific and programmatic impact of funded
projects. We will help pilot PIs craft high-impact proposals that have the potential to advance understanding
and treatment of CF, and help them gain access to local and national resources and collaborators to maximize
the value of their work. We will organize rigorous scientific review for pilot study proposals that include multiple
internal and external experts and uses the NIH scoring system. Funding will be based on scientific merit, the
project’s relationship to the CFRTC mission, links to the Cores, and projects' integration with the collaborative
groups of NIDDK-focused researchers our center has developed. We will oversee the scientific progress,
productivity, and finances of P&F projects.